Redesigning Medical specialty Outpatient DELivery through virtual SLEEP care (REMODEL-SLEEP)

Background: The VA is tasked with providing specialty care services for ~4 million Veterans annually, and
specialty care for obstructive sleep apnea (OSA) provides representative challenges and opportunities to
improve access to high-quality care. Almost 50% of Veterans are at high risk for OSA, and care to diagnose
and treat OSA can improve quality of life and health outcomes. However, the VA has limited capacity to meet
demands for OSA care with just over 300 sleep providers nationwide, and these specialists are concentrated in
VA medical centers (VAMCs), far from many Veterans. Referrals to community care providers represent one
strategy to meet demands for OSA testing, but these community referrals often lead to delayed and more
expensive care than necessary. As an alternative, a virtual approach incorporating E-consultation is used at
some VA medical centers to improve the reach and capacity of VA sleep providers. However, the effect of
virtual consults on important OSA treatment outcomes is unknown. Furthermore, virtual consults themselves
do not address the need for on-site services to train Veterans to use necessary testing and treatment
equipment. The nominee plans to address these gaps by refining and testing the feasibility and effectiveness
of a virtual consult pathway to provide care to Veterans at rural community based outpatient clinics (CBOCs).
His intervention will consist of virtual sleep consults supplemented with embedded respiratory therapists to
provide services on-site. The nominee also seeks to understand the cost implications of current approaches to
meet Veterans' OSA testing needs, and estimate the budget impact of expanding VA based services.
Significance/Impact: Dr. Donovan's research addresses three key VA priorities. (1) Provide greater choice
for Veterans: The virtual consult intervention will allow more Veterans to choose VA services rather than rely
solely on community care. (2) Focus resources more efficiently: His research pilots an intervention intended
to provide more affordable and effective OSA care. (3) Improve timeliness of care: The proposed work seeks
to improve access to proximal and timely sleep care for Veterans otherwise referred to the community.
Innovation: The virtual care intervention challenges the current medical center focused model of VA specialty
care. Dr. Donovan's intervention would redeploy respiratory therapists to provide necessary on-site services for
OSA care at CBOCs, obtain specialist input through E-consultations, and use VA ECHO telementorship
sessions to support the ongoing engagement and training of remote providers. In addition, Dr. Donovan plans
novel budget impact analyses to inform where it is more advantageous for the VA to expand existing sleep
services or purchase them from the community (i.e “make vs. buy”).
Specific Aims: (1) Assess Veteran and provider perspectives regarding initial OSA care. (2) Test the
feasibility and acceptability of a virtual consult pathway for initial OSA care. (3) Assess the nationwide impact
of community care referrals for OSA testing on diagnostic costs, timeliness to care, and treatment adherence.
Methodology: In Aim 1, Dr. Donovan will conduct qualitative interviews among 20 Veterans referred to sleep
care in the community, and 12 VA care providers. In Aim 2, Dr. Donovan will enroll 70 Veterans in a pilot
randomized trial of a virtual consult pathway versus community care referrals, and this pilot will address the
feasibility of procedures and data collection necessary for a definitive trial. In Aim 3, Dr. Donovan will assess
nationwide costs of OSA care for VA relative to Community Care. Dr. Donovan will use these costs to perform
budget impact analyses of expanding VA-based care relative to community care referrals.
Next Steps/Implementation: The research and training activities in this award will enable the nominee to
conduct a type I hybrid effectiveness-implementation trial. This multi-site trial will test the effectiveness of
virtual sleep care relative to community care referrals to improve patient reported OSA symptoms, experience,
and costs, while simultaneously engaging in a process evaluation to identify barriers to implementation.

Public health relevance
A major challenge for the VA lies in the provision of specialty services to the 50% of Veterans who require them, and one condition with a particular unmet need for specialty care is obstructive sleep apnea (OSA). Many Veterans are referred to community care providers to provide specialty access, but our preliminary data suggest these referrals can be costly and lead to delays in care. Using care for OSA as a model, our research seeks to inform the delivery of VA specialty services in a Veteran-centered, effective and efficient way. To do so, we will refine and pilot a program of virtual sleep consults to facilitate care within community based outpatient clinics. We will elicit perspectives from Veterans and health care providers to guide necessary adaptations to our program, and will pilot our intervention to obtain information essential to planning a definitive trial. We will also conduct nationwide cost and budget impact analyses to better understand costs of current practices, and project the costs of replacing community care referrals with VA-based services.